Research Training in Otolaryngology

We propose to continue our program of research training for residents in the basic sciences related to
Otolaryngology/Head and Neck Surgery at the University of North Carolina at Chapel Hill. The training
program consists of two tracks. The first track is for residents in the Otolaryngology program. One resident
in each incoming class receives 2 contiguous protected years of research training in the Department’s
research laboratories, starting after their surgical internship year, in preparation for careers as academic
Otolaryngologists and researchers. The second track is for one non-resident postdoctoral fellow per year,
who will be appointed to receive 2 contiguous years of training. All levels of the training program are
designed to provide cross-fertilization between the trainees in Otolaryngology with basic and clinical
scientists. Didactic elements of the training include a year-long course that covers diverse topics including
experimental design, research ethics, publication and grantsmanship, is designed to ensure the production
of outstanding researchers. Training progress is monitored with monthly research meetings and trainee
presentations. This training program is also extended to the regular non-research track residents, medical
students, graduate students, and postdoctoral trainees in the labs affiliated with the department. The
training faculty includes basic and clinical faculty of the Department of Otolaryngology/Head and Neck
Surgery at the University of North Carolina at Chapel Hill, and selected faculty from other departments
whose research interests intersect with Otolaryngology/Head and Neck Surgery. Research areas include
auditory neurobiology, cochlear implants, auditory perception, cancer mechanisms, head and neck cancer
epidemiology, and sinus and airway function. An External Advisory Committee with expertise related to the
research training tracks represented by the program provides guidance regarding the overall program. An
Internal Advisory Committee provides additional oversight of the training program and helps guide trainee
selection. The long-term goal is to produce academic clinicians and basic researchers in the field of
Otolaryngology/Head and Neck Surgery with exceptional research credentials.

Public health relevance
Research Training in Otolaryngology is a formal research training program at the University of North Carolina at Chapel Hill for Otolaryngology/Head and Neck Surgery (ear, nose and throat) residents and postdoctoral fellows in sciences related to otolaryngology. Training areas include the hearing sciences and neuroscience, cochlear implant research, head and neck cancer research, and sinus and airway function. The program seeks to train outstanding academic clinicians and scientists who can carry out bench-to-bedside research related to Otolaryngology/Head and Neck Surgery.